Telomerase-Mediated Healing of Double-Strand Breaks in Human Cells

PROJECT SUMMARY/ABSTRACT
Telomeres—which define and protect the ends of humans’ linear chromosomes—serve as a natural check on
carcinogenesis. Genome stability requires cells to differentiate telomeres from perilous DNA double-strand
breaks (DSBs) to block inappropriate DSB repair and DNA damage response (DDR) signaling, which humans
accomplish with the shelterin complex. Telomerase maintains telomere length in the gonads and some stem
cells, but telomeres in somatic cells shorten with each cell division due to developmental silencing of
telomerase. Unfettered cell division in early neoplasms eventually leads to a few telomeres becoming critically
short and activating persistent DDR signaling, which causes cells with functional p53 and Rb pathways to
undergo senescence or apoptosis. Cells defective in these pathways continue to divide until multiple telomeres
become de-protected and then enter telomere crisis, defined by poor cell viability due to intolerable genomic
instability, as chromosomes repeatedly fuse at their ends and break. Clinical tumors emerge from crisis with
rearranged, aneuploid genomes and a telomere maintenance mechanism. To escape from telomere crisis, I
predict that malignant cells must reconstitute their telomeres and that telomerase may accomplish this by
directly repairing non-telomeric chromosome ends with neotelomeres.
The objective of the proposed project is to identify and mechanistically characterize telomerase-
mediated DSB repair in human cells. In vitro, telomerase can add TTAGGG repeats to a non-telomeric
breakpoint sequence derived from a patient with α-thalassemia due to a terminal chromosomal truncation.
Using this sequence, I have designed a PCR-based reporter assay to detect neotelomere formation in cells at
an inducible DSB and have gathered evidence that suggests that telomere healing occurs in human cells in a
telomerase-dependent manner. I will improve this assay with TaqMan probes on a qPCR platform to rigorously
quantify telomere healing events and will perform further experiments to demonstrate that telomerase is
responsible for TTAGGG repeat addition. Because telomerase-mediated repair threatens to convert DSBs into
terminal chromosome deletions, I hypothesize that human cells have evolved mechanisms to block telomerase
activity at DSBs. I will implement a genetic approach with my telomere healing assay to identify the physiologic
repressors of this aberrant mode of DSB repair. Ultimately, I aim to unveil a new role for telomerase in enabling
incipient cancers to traverse the bottleneck of telomere crisis. This leap in our understanding of genomic
instability in early tumorigenesis may lead to unexpected ways to detect and prevent cancer in patients. With
the aid of this award and the stimulating environment of the Tri-Institutional MD/PhD Program, I will grow
scientifically, medically, and professionally in ways that will enable me to advance toward my long-term career
goal of leading a cancer-centric lab while providing patient care as a transformative physician-scientist.

Public health relevance
PROJECT NARRATIVE Telomere shortening impedes uncontrolled cell division either by triggering replicative senescence or apoptosis or by running transformed cells into telomere crisis, in which rampant end-to-end telomere fusions and chromosome rupture restrict cell viability. This project aims to identify the molecular mechanism and physiologic repressors of telomerase-mediated DNA double-strand break repair, which may enable transformed cells to escape telomere crisis and emerge as clinical tumors. My anticipated findings will illuminate another facet of genomic instability in early tumorigenesis and may lead to novel strategies for cancer diagnosis and prevention.